GENICULO CORTICAL SYSTEM OF VISUALLY DEPRIVED

The goals of this proposed research are to define the effects of monocular deprivation on area 18, determine if area 18 is capable of recovery from the abnormalities caused by monocular deprivation, and demonstrate how the connectivity pattern between the lateral geniculate nucleus (LGN) and the visual cortex is altered by monocular deprivation. Area 18 is an integral part of the geniculo-cortical system and is especially interesting since it is dominated by Y-relay cell input(1,2). Little is known about the effects of monocular deprivation on area 18(3,4) in contrast to the LGN(5-11) and area 17(12-16). Thus, the effects of monocular deprivation in a major portion of the developing geniculo-cortical system remain ill-defined. Furthermore, in monocularly deprived (MD) cats when the non-deprived eye is removed and the deprived eye is opened (allowing for normal pattern vision), there is a complete recovery of the Y-cell population 6. These recovered Y-cells do not drive neurons in area 17(13,17). However, they may have access to cortical processing through area 18, a structure dominated by Y-cell input in normal cats. Four specific sets of experiments are designed to define the functional and structural changes occurring in the geniculo-cortical system following monocular deprivation and subsequent recovery. The proposed experiments will: 1) define the projections of the lateral geniculate nucleus to area 18, allowing for between group comparisons; 2) demonstrate the physiological effects of suturing one eyelid closed on single area 18 neurons; 3) determine if single neurons in area 18 of monocularly deprived cats are capable of recovery, defining the conditions necessary and sufficient for recovery to occur; and 4) determine if the projections of the lateral geniculate nucleus to areas 17 and 18 are altered by visual deprivation, using double label transport methods.